Enhancing bacteriophage function with coevolution and synthetic biology

Project Summary/Abstract:
Antimicrobial resistance (AMR) poses a growing threat to human health, with nearly 5 million deaths worldwide
attributed to AMR bacterial infections in 2019. There is a growing critical need for innovative treatments for AMR
infection, and phage therapy, which uses naturally occurring viruses that attack bacteria, is emerging as a
potentially powerful treatment modality. Phage therapy is limited by the ability of bacteria to evolve resistance to
phages, but phages have the capacity to evolve counter-resistance. We do not fully understand the diversity of
ways that phage can evolve to overcome a wide variety of bacterial resistance strategies. The overall objective
of this proposal is to use experimental evolution in the laboratory to identify genetic changes in phages that are
responsible for enhanced phage function, and to engineer phages that have optimized traits to suppress bacterial
growth. The experiments in specific aim 1 will examine the genetic and functional patterns underlying enhanced
phage function when phage T2 is evolved alongside a variety of diverse clinical isolates of Escherichia coli. The
experiments in specific aim 2 will identify the causative mutations in evolved phages, their optimal combinations,
and the associated mechanisms of action. This work will contribute new insights to phage-bacteria interactions
that will assist in the design of engineered phage therapies, as well as collections of genetically and functionally
characterized evolved and engineered phages with enhanced antibacterial function. This proposal is designed
to support the career development of the candidate, who will expand expertise in the microbiology of bacteria
and phages, microbial genomics, and experimental methods in synthetic biology. The proposed work is expected
to identify new mechanisms that phages can exploit to overcome bacterial resistance, providing the groundwork
for the candidate to develop independent lines of research.

Public health relevance
Project Narrative Phages are viruses that naturally infect and kill bacteria and can be used in the treatment of antimicrobial resistant bacterial infections. Bacteria use diverse mechanisms to resist phage attack, and phages can evolve counter strategies. This project aims to identify molecular mechanisms that phages use to antagonize bacterial defenses and characterize how phages can evolve or be engineered to obtain enhanced antibacterial function that can be useful to treat antimicrobial resistant infections.